Effect of right-ventricular structural remodeling during pressure overload on the mechanical behavior of myofibers in excised human myocardium

ABSTRACT
Chronic pressure overload in the right ventricle (RV), such as that experienced in pulmonary hypertension (PH),
leads to structural remodeling of the myocardium as the RV attempts to maintain hemodynamic function.
Remodeling is characterized by chronic stiffening and rearrangement of the myofiber layers that compose the
myocardium, which is thought to play a significant role in the late stages of RV failure. The underlying
microstructural mechanisms and the precise role of remodeling of the RV during disease progression are not
well understood, largely due to the inability of current cardiac imaging modalities and biomechanical experimental
techniques to probe the myocardium microstructure either in vivo or in bench-top experiments. In this F32, a new
and unique bench-top experimental configuration is proposed that can directly detect myofiber stretches and
rotations during two-dimensional passive stretch of excised human RV tissue using ultrasound imaging. The
sub-wavelength ultrasound imaging technique is based on calculation of the spatial coherence of the
backscattered ultrasound field, and has translational potential for clinical use. The experimental configuration
will be used to directly assess the mechanical behavior of RV myofibers during passive stretch in excised human
RV tissues that have undergone structural remodeling during chronic pressure overload. Thus the proposed
experiments will elucidate the micromechanical nature of RV structural remodeling. Histological sectioning will
allow for direct correlation between microstructural remodeling and the measured differences in mechanical
response between remodeled myocardium and healthy control tissue, thus shedding light on the microstructural
origins of structural remodeling of the RV during chronic pressure overload. Specific Aim #1 employs passive
stretches that occur much slower than during diastole, thus approximating static deformations. Specific Aim #2
investigates stretches that occur at similar rates to those experienced in vivo during diastole, thus the dynamic
passive mechanical behavior of RV myofibers will be explored.
The proposed research is part of a multifaceted training and professional development plan that will take place
during the award period. The experiments and analyses associated with the execution of the Specific Aims will
involve in-depth and hands-on training experience for the applicant in both biomedical ultrasound imaging and
experimental biomechanics research techniques. Co-mentors for the proposal have successful track records in
translational biomedical research, thus training will include experience in bridging the gap between basic
research and translation into clinical applications – the so-called “valley of death.” The collaborative environment
within the Vascular Medicine Institute at the University of Pittsburgh Medical Center includes a culture that is
dedicated to the training of NIH T32 and F32 trainees, and provides a wealth of opportunities to share and
discuss advances with leading investigators in basic, translational, and clinical research in the field of vascular
medicine through seminars, conferences, and other opportunities for professional development.

Public health relevance
PROJECT NARRATIVE Structural remodeling of the right-ventricle during chronic pressure overload in the setting of pulmonary arterial hypertension (PAH) is a critical problem and a key determinant of survivability (70% of diagnosed cases of PAH end in right-heart failure), but the underlying causes of ventricular remodeling are not known. Using a new ultrasound imaging technique, we will perform the first measurements of the mechanical behavior of right- ventricular myofibers in excised remodeled human myocardium during two-dimensional passive stretch in a biaxial testing configuration. Unique insights that will be gained from the measurements will elucidate the underlying mechanical origins of ventricular remodeling during pressure overload, and pave the way for new preventative, therapeutic, and curative treatments of diseases like pulmonary hypertension.